Field-deployable analyzer for aqueous uranyl concentration

This NIH SBIR Phase I project addresses the critical need for rapid, in-field, and accurate monitoring of
uranium in drinking water sources. Uranium contamination poses severe environmental and public health
risks, particularly affecting vulnerable populations. Currently, available rapid colorimetric tests lack the
sensitivity required for research and clinical purposes, demanding skilled labor and capital-intensive
equipment for accurate detection. We aim to bridge this gap by developing an innovative Surface-Enhanced
Raman Spectroscopy (SERS)-based platform capable of real-time, trace-level uranium quantification in water.
In Phase I, we will focus on developing the essential chemistry for uranyl detection using our proprietary SERS
platform. This entails creating a calibration curve with laboratory standards to achieve quantification
exceeding 10% accuracy and a detection limit below 30 ppb, aligning with the EPA Maximum Contaminant
Level. Subsequently, we will validate the detection strategy by evaluating its performance against known
interferents in lab standards and applying it to thirty real-world water samples. Rigorous testing and
comparison with established laboratory techniques will demonstrate the method's accuracy and reliability.
Our research design harnesses state-of-the-art SERS technology, offering rapid, on-site uranium
quantification. Successful completion of these aims will significantly contribute to enhanced water quality
assessment and informed decision-making, ultimately safeguarding public health and the environment. This
project serves as the cornerstone for subsequent phases, including commercialization and widespread adoption
of this groundbreaking technology.

Public health relevance
Project Narrative This project addresses the pressing public health concern of uranium contamination in drinking water. By developing a novel Surface-Enhanced Raman Spectroscopy (SERS)-based platform for real-time uranium quantification, this research aims to provide accurate and rapid monitoring tools. In the long term, this innovative technology will significantly improve water quality assessment, contributing to better public health protection and environmental preservation.